Mammalian models for integrated metabolic and molecular profiling of malignant glioma

PROJECT SUMMARY/ABSTRACT
Translational cancer research requires robust preclinical models to most effectively investigate the underlying
biology of disease and develop new therapeutics. While all models are imperfect, it is essential to understand
the degree by which each model system (e.g., cell culture, xenograft) recapitulates specific molecular and
functional characteristics of human tumors. This may be particularly relevant for studying altered metabolism, a
hallmark of cancer, as even subtle changes to the environment can greatly impact the metabolic phenotype of a
tumor. Moreover, as cancer metabolism is tightly regulated by oncogenic signaling, the diversity of molecular
alterations within a given malignancy may elicit unique metabolic characteristics; which, may greatly influence
metabolic pathway dependencies for tumor proliferation and growth. To best determine the fidelity of preclinical
models in preserving the metabolic features of human cancer, this requires cross-comparing matched patient
tissue and preclinical models across tumors with various genetic alterations. However, such a comprehensive
investigation has yet to be undertaken. This proposal will perform an integrated metabolic and molecular
characterization of matched human tumors, direct-from-patient orthotopic xenografts (GliomaPDOX), and cell
lines from patients with glioblastoma (GBM) – one of the most lethal human malignancies that also reside within
the unique brain metabolic milieu. In Aim 1, stable isotope-labeled metabolic tracing and liquid chromatography-
mass spectrometry (LC-MS) will be used to cross-compare the metabolic phenotypes of prospectively matched
GBM patient tumors, GliomaPDOX, and cell lines to determine the metabolic characteristics that are preserved
and/or lost from patient to preclinical model. Aim 2 proposes to determine, in genetically diverse preclinical
GliomaPDOX models, whether specific metabolic phenotypes align with distinct molecular signatures. Finally, in
Aim 3, in vivo genetic knockdown experiments will be performed to assess whether measured metabolic
phenotypes represent targetable dependencies for GliomaPDOX growth, invasion, and survival. Collectively, the
studies proposed in this application will provide critical insight into the translatability of preclinical GBM models
for studying tumor metabolism; which, may ultimately have important implications for developing new
therapeutics against metabolic dependencies in GBM, and potentially, other malignancies.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Patients with glioblastoma (GBM) have a dismal prognosis and, similar to other malignancies, GBM exhibit metabolic reprogramming to support rapid tumor growth and proliferation. Herein we propose to use quantitative analysis of tumor metabolites and next-generation sequencing to cross-compare the metabolic and molecular characteristics of matched GBM patient tumors, orthotopic mouse xenografts and cell lines to evaluate the fidelity of preclinical models in recapitulating the metabolic phenotype of human tumors. Collectively, the results obtained from this proposal will determine the translatability of preclinical GBM models for investigating tumor metabolism.